MURI - BRAIN/BLAST INJURY MOUSE CT DATA SHARING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. My name is Kyle Matthews, and I am an Associate in Research in the Bass/Nightingale/Myers lab in the Duke BME department. I obtained your name from a coworker, Jason Luck, who has previously worked with the CIVM on the constitutive properties of pediatric PMHS neurocentral synchondrosis. Jason recommended the Duke CIVM to me due to your department working extensively with micro CT scans of mice in the past. The project I am currently working on requires a whole-body postmortem mouse CT scan, and I am hoping that contacting you is the appropriate channel for requesting access to such data, if it is available.